Disclipine A: Microbiology - Analytical Track Animal Food Product and Environmental Testing

Abstract PROJECT TWO: Texas Animal Food Product and Environmental Testing for Microbiological Hazards Office of the Texas State Chemist (OTSC) has the ability to screen and/or confirm the following organisms: Salmonella spp. in animal food, animal food ingredients, biosolids, human food; Shiga like toxin producing E.coli (STEC) O157:H7 and non-O157 in animal food, animal food ingredients and human food; Listeria monocytogenes in raw milk, animal food and animal food ingredients, human food; SEB in raw milk, Brucella spp. antigen in raw milk, ricin toxin via Tetracore ELISA, Shigella spp. in human food, Bacillus anthracis sterne in human food, Staphylococcal enterotoxins in human food, T-2 toxin and alpha- amanitin by LCMSMS. The microlab received BSL3 training in screening methodologies of Bacillus anthracis and Yersinia pestis at USAMRIID facility, Ft Detrick, MD in 2018 and are moving forward to establish this method (screening and confirmatory) at OTSC facility. The OTSC-AAS microbiology lab is in process of bringing its microbiology capabilities under the OTSC ISO/IEC 17025:2017 scope which will occur prior to project startup. The OTSC Animal Food Product and Environmental Testing, Microbiology testing project plan includes: 1) collecting samples by OTSC field investigators using approved sampling methodology and chain-of-custody, 2) analyzing 500 samples for Salmonella and Listeria monocytogenes, and 50 samples for prohibited mammalian tissue, 3) reporting presumptive positives within 1 day and confirmatory results within 3 days, and 4) removal of contaminated product from the market. As an outcome of this project, Texas animal food surveillance of microbiological hazards will be strengthened, scope of ISO accreditation expanded, laboratory capacity and capability increased, and surveillance of animal food for microbiological hazards will reduce risk and product adulteration from these contaminants.